Administrative Core

Administrative Core Abstract
The HPC Administrative Core provides the administrative support needed to ensure that the scientific goals of
the HPC are accomplished. The goals of the Core are to support the leadership of the Center and coordinate
its relationships with advisory groups, University initiatives, and outside entities; to manage the basic
infrastructure of the Center and ensure that the Development and Scientific Cores work smoothly together; to
disseminate HPC Associates’ research and facilitate networking and collaboration; and to conduct oversight for
the Center as a whole, undertaking evaluations of the HPC’s success in accomplishing its overall goals and
reporting back to the leadership and Faculty Coordinating Committee on evaluation metrics. The Core is led by
Dr. Emily Agree (Associate Director of the HPC). The Core is staffed by the HPC Assistant Director, an
Administrative Coordinator, an IT Specialist, and a population Informationist. This Core is critical to the success
of the HPC. It makes sure that the services of the Development and Scientific Core are provided efficiently,
and that they are complementary and coordinated. While the Development and Scientific Cores more directly
address Associates’ research and career development needs, the Administrative Core is essential to the
effective delivery of all Center services. The HPC brings together Associates not only across disciplines, but
also bridges seven schools across campuses of Johns Hopkins University, making central administration of
services especially important to our success. The Administrative Core ensures that equal access to support is
available to all Associates, that our seminars and workshops are accessible across campuses, and that our
Associates’ research is broadly disseminated both within and outside the university. The Administrative Core
also is critical to monitoring our progress toward target goals for success, reviewing new directions, and
changing services and delivery as needed.